Multi-omic network methods for mapping molecular trajectories of age-related lung diseases

Chronic obstructive pulmonary disease (COPD) and idiopathic pulmonary fibrosis (IPF) are progressive lung
diseases that are substantial sources of morbidity and mortality worldwide. Both diseases have common
origins beginning with injury to the lung from environmental exposures such as cigarette smoke or particulates
from biomass fuels. However, people with similar exposures have divergent outcomes: some people develop
COPD, some develop IPF, and some develop neither condition. Moreover, COPD and IPF are both highly
heterogeneous conditions. While genetic factors can explain a small amount of this variability, the molecular
mechanisms underlying these divergent outcomes are largely not understood. We hypothesize that the
diversity in COPD and IPF is a reflection of the interaction of genetic differences with environmental factors,
thus explaining how similar exposures can result in such broadly varying phenotypes. We propose that these
gene-environment interactions can be assessed across the genome by incorporating an epigenetic perspective
into models of genetic and genomic variation in lung disease. This application will support the development
and application of new multi-omic methods needed to elucidate the shared and divergent biology underlying
COPD and IPF. Specifically, the new methods will 1) map conditional dependence between genotype, gene
expression, and DNA methylation in a mixed graphical model framework; 2) use multi-omic networks to identify
a panel of genes involved in the differential etiology of COPD and IPF; and 3) map lung disease trajectories
using network embedding of multi-omic similarity networks constructed from controls, COPD cases, and IPF
cases. Dr. Shutta is a biostatistician with training in mathematics, computer science, statistics, and systems
biology. Her goal is to become an independent investigator conducting research into complex pulmonary
diseases by developing and applying novel methods for multi-omic integration in network medicine. Dr.
Shutta’s training will be conducted jointly at the Harvard School of Public Health and at the Channing Division
of Network Medicine (Brigham and Women’s Hospital/Harvard Medical School). In these neighboring
institutions, Dr. Shutta will have access to two complementary and rich training environments - an ideal setting
to pursue the integrative work in this proposal by connecting with methods-focused biostatisticians at HSPH
and clinically-focused researchers and physician-scientists at BWH/HMS. Dr. Shutta’s path to independence
will be supported by experienced mentors, an advisory committee, and top-quality didactic training in
respiratory pathophysiology, numerical optimization, and scientific computing. The work completed during this
proposal will support Dr. Shutta’s path to independence as a biostatistician and contribute new understandings
of the biology of COPD and IPF.

Public health relevance
Exposures to environmental irritants such as cigarette smoke can cause chronic obstructive pulmonary disease (COPD) or idiopathic pulmonary fibrosis (IPF), both of which are chronic, incurable lung diseases that substantially reduce quality of life and shorten the lifespan. However, not everyone who is exposed develops lung disease, and for those who do, the disease phenotypes are highly variable. In this proposal, new methods will be developed to explore this diversity by elucidating epigenetic mechanisms for the interaction of the environment with each individual’s unique genome using network science techniques, potentially identifying therapeutic targets that could improve patient outcomes in COPD and IPF.